Enriching Neuro-Oncology Survivorship: A Novel Symptom Management Education to Living Fully (SELF)

PROJECT SUMMARY
The purpose of this NIH/NCI Pathway to Independence Award for Early-Stage Postdoctoral Researchers
(K99/R00) is to provide research training during the K99 Phase for Karl Cristie Figuracion, PhD, ARNP, a first-
year postdoctoral research fellow at the Fred Hutchinson Cancer Center (Fred Hutch)/University of Washington
(UW), and to become a productive, independent scientist during the R00 Phase with a research program
focused on interventions to reduce symptom burden, improve quality of life (QoL), and return-to-work (RTW)
outcomes in brain tumor survivors. This K99/R00 proposal outlines a training and career development plan that
builds on and expands Dr. Figuracion's research skills to become a competitive applicant for a tenure-track
faculty position at a research-intensive institution. Training Plan: To expand her research toolkit and advance
her transition to independence, Dr. Figuracion assembled a multidisciplinary team of expert mentors from Fred
Hutch and UW. Together with her mentors, they designed a robust training plan that includes regular mentored
meetings and relevant advanced coursework, seminars, workshops, and research activities. The specific
Learn the fundamental methods to develop a symptom management
education intervention; 2) Receive didactic and hands-on training in qualitative study designs and analysis; 3)
Gain didactic and hands-on training in
analysis; and 4) Tra
training goals of the K99 phase are to: 1)
intervention design and implementation, clinical trial design, and
nsition to an independent scientist by building a publication record in cancer survivorship
and neuro-oncology survivorship research. Research plan: Isocitrate dehydrogenase (IDH) mutant glioma BT
survivors experience significant symptom burden that impacts their overall QoL and RTW outcomes after
radiation therapy (RT). However, there are limited symptom management interventions to improve self-
management skills and health outcomes after RT. During the K99 Phase, Dr. Figuracion will refine a novel 5-
session intervention, Symptom Management Education to Living Fully (SELF), which she developed in
collaboration with subject matter experts. Specific Aim: 1) Refine SELF curriculum content through focus
groups with IDH mutant glioma BT survivors (n=6-8), caregivers (n=6-8), and clinical care team (n=6-8). During
the R00 Phase, she will test the feasibility and preliminary efficacy of SELF on reducing symptom burden and
improving QoL, and RTW outcomes in IDH mutant glioma BT survivors (n=40). Specific Aims: 2) Test the
study design feasibility as assessed via recruitment, adherence, retention, fidelity, and acceptability; 3)
Examine the preliminary efficacy of SELF on self-efficacy, symptom burden, QoL, and RTW outcomes; and 4)
Explore the preliminary effects of SELF on health promoting behaviors. Data generated in the R00 will serve as
preliminary data for a future R01 efficacy trial to test the effects of SELF on increasing self-efficacy, reducing
symptom burden, and improving QoL and RTW outcomes in BT survivors. The research generated from this
K99/R00 will advance symptom management interventions to improve health outcomes in BT survivors.

Public health relevance
PROJECT NARRATIVE Isocitrate dehydrogenase (IDH) mutant glioma brain tumor survivors experience significant symptom burden that impacts their overall quality of life (QoL) and ability to return to work (RTW), and yet, limited symptom management interventions exist to improve self-management skills and health outcomes after treatment. Thus, we propose to refine a novel intervention we developed called Symptom Management Education to Living Fully (SELF) through qualitative focus groups (K99 Phase) followed by a pilot study to test the feasibility and preliminary efficacy (R00 Phase) of the SELF intervention on self-efficacy, symptom burden, QoL, and RTW outcomes in IDH mutant glioma brain tumor (BT) survivors after radiation therapy (RT). We hypothesize that the SELF intervention will be feasible and increase self-efficacy, reduce symptom burden, and improve QoL and RTW outcomes among IDH mutant glioma BT survivors after RT.